Administrative

The Administrative Core provides oversight of Vanderbilt Center for Metabolic Phenotyping in Live Models of
Obesity and Diabetes (VMPMOD) activities. This Core ensures that the Center operates efficiently, has a
sustainable financial model, and is responsive to the needs of the national scientific community and the
recommendations of standing committees. The Administrative Core supports all functions of VMPMOD which
include (a) evaluation of the suitability of mice submitted for study to the Center, (b) consultation with
investigators in conjunction with core staff for testing procedures on mice submitted to the Center, (c) oversight
of research and development, (d) oversight of the outreach/educational component including Vanderbilt
Vibrant, (e) data management in conjunction with the National Program Coordinating Unit, and (f) interaction
and coordinating services with other members of the consortium. This Core is also responsible for ensuring
VMPMOD functions within guidelines established by Vanderbilt University School of Medicine and the Program
National Steering Committee. The Administrative Core consists of the Center Director, Associate Director,
Associate Director for Vanderbilt Vibrant, Resource Statistician, and Program Manager. In addition, the
Administrative Core receives recommendations from three standing committees. The Center Executive
Committee consists of the Center Director and faculty with different perspectives necessary for the success of
the VMPMOD. The Executive Committee receives input from other committees and provides recommendations
to improve center operations. It consists of the Center Director, directors of other NIDDK-funded center
programs, chair of the department home of VMPMOD, the Vice President of Animal Care, and the Vice
Chancellor for Equity, Diversity, and Inclusion. The Center Research Advisory Committee (RAC) consists of
Core and Subcore Directors and Vanderbilt faculty with specific areas of expertise in studies of the mouse that
are used by the VMPMOD. RAC meets to evaluate whether tests are performed with rigor and are reproducible
and to provide recommendations on services that warrant expansion or expiration. VMPMOD providesunique
services and expertise exclusively to investigators without direct affiliation to Vanderbilt. The External Advisory
Committee (EAC) is comprised of external investigators from diverse backgrounds and at different career
stages. EAC meets virtually to provide input that assists the VMPMOD to serve investigators most effectively.
Center Director, Core Directors, Subcore Directors, and the Program Manager are ex officio members of the
EAC. The EAC provides vital input to the RAC and the Center Executive Committee that informs VMPMOD
actions. The Administrative Core actualizes Vanderbilt Vibrant. This Core targets outreach programs to ensure
that Vanderbilt Vibrant eligible investigators receive the considerable benefits of the program. The
Administrative Core participates in the National Consortium and directly interact with the National Consortium
Coordinating Unit.